Building mobile HIV prevention and mental health support in low-resource settings

Project Summary
This project is designed to remedy unaddressed and interlocking HIV-prevention and mental health needs
among gay and bisexual men (GBM) in the Central Eastern European country of Romania, and their
underpinning stigma-related mechanisms. Rampant stigma contributes to the increasing prevalence of HIV
among Romanian GBM (from under 10% in 2009 to close to 20% in 2014, by best available estimates) and
keeps GBM out-of-reach of HIV-prevention services. Our mHealth pilot intervention (titled “Despre Mine.
Despre Noi.” [DMDN] translated as “About Me. About Us.”), which reduced US and Romanian GBM’s risk for
HIV infection while also reducing depression and alcohol abuse in initial pre-post trials, is now ready for testing
in a randomized controlled trial with a large national sample. The DMDN intervention entails eight 60-minute
live chat sessions delivered by trained counselors on our mobile study platform using motivational interviewing
(MI) and cognitive-behavioral skills training (CBST). First, during pre-trial (mos 1-5), in collaboration with a
community advisory board consisting of GBM community members, GBM-affirmative physical and mental
health providers, and our technical developer, we will fine-tune the DMDN intervention based on our pilot
findings and evaluation interviews, and expand the original DMDN education materials for an education
attention condition (EAC) that will serve as our control. Second, during the intervention phase (mos 6-45), we
will recruit, screen, assess, and randomize GBM at risk for HIV infection and alcohol abuse to either the DMDN
intervention (n=163) or EAC (n=163). The conditions are content matched, and both are hosted on our study
platform. While DMDN will consist of eight weekly mHealth live chat sessions, EAC will consist of eight self-
administered educational modules. Third, during the follow-up phase (mos 8-55), we will assess at 4, 8, and 12
months post-baseline, in a mobile fashion identical to the baseline, the primary outcome of condomless anal
sex with male partners and secondary outcomes of alcohol abuse, depression, biologic HIV/STI infection,
HIV/STI testing, and psychosocial mechanisms rooted in the Information-Motivation-Behavioral Skills (IMB)
model (e.g., HIV/STI knowledge, condom use self-efficacy) and minority stress theory (e.g., identity
concealment, internalized homophobia). We hypothesize that 1) compared to GBM randomized to EAC, those
randomized to the mHealth DMDN condition will report significant reductions in condomless anal sex across
the 12-month follow-up, 2) IMB and minority stress mechanisms will statistically mediate intervention efficacy,
and 3) compared to EAC, the DMDN intervention will prove cost-effective in terms of HIV infections averted
and reduced depression and alcohol abuse. If efficacious and cost-effective, DMDN presents a highly
disseminable intervention that could significantly prevent HIV infection among GBM in high-stigma, low-
resource areas, where GBM are disproportionately affected by HIV, yet kept out-of-reach of brick-and-mortar
prevention services.

Public health relevance
Project Narrative This project will test the efficacy of a promising mobile intervention to remedy unaddressed and interlocking HIV-prevention and mental health needs, and their underpinning stigma-related mechanisms, among gay and bisexual men (GBM) in Romania. If shown to be efficacious and cost-effective in this proposal, the intervention will provide local health providers with a needed tool to support the substantial HIV-prevention needs of underserved Romanian GBM. The intervention’s mobile nature possesses significant promise for efficiently and durably reaching otherwise hard-to-reach GBM living in high-stigma, low-resource locales across Eastern Europe, the US (e.g., rural Appalachia), and beyond.